Distinct innate immune responses to HSV-1 versus HSV-2 genital infection determine extent of neuronal infection.

PROJECT SUMMARY/ABSTRACT
Genital herpes (GH) is a common sexually transmitted infection with significant morbidity and no vaccine or cure.
It is caused by Herpes Simplex Virus-1 (HSV-1) or HSV-2. Patients who have HSV-2 GH experience significantly
higher frequency of disease recurrence and transmission than patients with HSV-1 GH. Previous studies linked
frequency of reactivation to reservoirs of latent virus in the peripheral nervous system (PNS) that were
consistently larger after HSV-2 genital infection relative to HSV-1. However, it was unknown whether these
disparate outcomes were due to intrinsic viral properties or the host response. To explore the latter, our lab
utilizes direct comparisons of murine models of HSV-1 and HSV-2 vaginal infection. From these, we identified
that HSV-1 induces an accelerated adaptive immune response relative to HSV-2, better protecting the PNS from
viral invasion. Increased neuroprotection was linked to an early burst of NK cell dependent IFNg that was
secreted in the vagina one day after HSV-1 but not HSV-2 infection. However, the upstream signals driving
differential kinetics of NK activation between each model as well as the downstream mechanisms conferring
increased neuronal resistance to infection are both unknown. The central hypothesis of this proposal is that HSV-
1 genital infection is sensed by local immune cells faster than HSV-2, leading to rapid mucosal secretion of IFNγ
that directly enhances neuronal resistance to infection. Previous studies have identified a key role for
inflammatory monocyte IL-18 in activating NK cells to produce IFNg during HSV-2 infection. Preliminary data
suggests a trend towards faster recruitment of this population during HSV-1 infection, correlating with earlier
IFNg production. To follow up, I will compare the mechanism of inflammatory monocyte recruitment during HSV-
1 vs HSV-2 infection and identify the distinct responses that differentially regulate vaginal NK cell recruitment
IFNg production (Aim 1). IFNg is a known inducer of autophagy in other host-pathogen responses, and autophagy
is one of the primary non-lytic mechanisms by which sensory neurons control HSV infection. Therefore, I will
also explore the novel potential crosstalk between mucosal NK cells and the PNS by evaluating whether IFNg
can augment autophagic flux in sensory neurons in vitro and in vivo as a mechanism to control HSV infection
(Aim 2). The long-term objective of this proposal is to define the distinct innate immune responses to HSV-1 vs
HSV-2 genital infection as a method to identify the requisite features of a host response that successfully limits
neuronal invasion. Such investigation would be invaluable for informing future vaccine design that is effective
against both viruses. In pursuit of this first objective, I will achieve my second objective of further developing my
autonomy as an independent researcher through a carefully crafted training plan developed with my sponsor,
Dr. Haina Shin, and co-sponsor, Dr. Wayne Yokoyama, that will i) enhance my research skills, ii) strengthen my
abilities in scientific communication, and iii) provide mentorship and professional development opportunities to
achieve my career goals to be a future physician-scientist and academic investigator in infectious disease.

Public health relevance
PROJECT NARRATIVE Genital herpes is one of the most common sexually transmitted infections, affecting 1 out every 8 Americans under 50 years old. Patients with genital herpes caused by Herpes Simplex Virus type 2 (HSV-2) experience higher frequency of symptom recurrence than those with disease caused by HSV-1, which may be linked to the degree of neuronal invasion by virus. In this proposal, I will elucidate the differences in the mucosal immune response to HSV-1 versus HSV-2 genital infection and establish how early innate responses determine extent of neuronal infection and long-term disease outcomes.